Effects of Prenatal Alcohol Exposure on Alzheimer's Disease-associated Neuropsychiatric Symptoms

PROJECT SUMMARY / ABSTRACT
Alzheimer’s disease (AD) is the most common cause of dementia, affecting 3–11% of the
United States elderly. On the other hand, the estimated incidence of prenatal alcohol
exposure (PAE)-induced mental disability or disease is 10 per 1000 live births. Although
theoretically PAE-induced mental diseases are preventable, the prevalence of PAE has
been reported to be as high as 10%-16.3%. Among a broad spectrum of PAE and AD-
associated symptoms, progressive impairment of cognition has been extensively
investigated. However, limited symptomatic relief in these patients by available
medications demonstrates lack of understanding of the neuronal substrates, especially
the PAE and/or AD-associated neuropsychiatric symptoms (NPSs). It is well accepted
that apathy, the top ranked NPS in both PAE and AD, arises through interactions between
genetic and environmental factors. PAE has been considered an environmental insult to
the brain and AD high risk genes have been identified as top genetic factors facilitating
the onset of NPSs. Together with the increased life expectancy by 8-10 years in the USA
in the last 50 years, the evaluation of interactions between PAE history and AD high-risk
genes at the molecular, synaptic, circuit, and behavioral levels is highly urgent. Our
awarded parent R01 grant focused on exploring changes of excitatory synaptic
transmission to the nucleus accumbens (NAc) underlying the synaptic loss and the low
motivation phenotype in subjects with high risk of AD and a history of PAE. Besides the
synaptic transmission, evaluation of a brain region’s functional output is directly related
to the excitability of the projecting neurons in that region. Thus, in this Administrative
Supplement proposal as a response to PA-18-591, we will focus on the excitability-related
readouts, including the number of action potentials measured by whole-cell patch clamp
and the calcium transient activity measured in vivo and ex vivo.

Public health relevance
PROJECT NARRATIVE Apathy, as one of the top ranked symptoms of both Alzheimer’s disease (AD) and maternal alcohol consumption, has been understudied but significantly affects the life of patients and caregivers. The goal of this project is to uncover the changes in excitability of the nucleus accumbens, a brain region associated with motivational output, in those prenatally exposed to alcohol and also having high risk for AD. This may significantly improve the life quality of AD patients, decrease caregiver burden, lower the cost of care, and minimize premature institutionalization.